Tipping Points in Cancer

A new program project on Tipping Points in Cancer will address fundamental questions about processes
in cancer initiation and progression. The premise of the program is that cancer develops through a series
of stochastic steps, some of which are non-genetic (i.e., not mutational), including steps that are non-cell-
autonomous (i.e., collective). Three team-oriented research projects will investigate cell states and cell-
cell interactions that drive such transitions and explore their impact on cancer prevention and therapy.
Each project deals with a cancer that, when modeled using genetically engineered mice, points to the
existence of unexplained thresholds in the transition between pre-malignant and malignant states.
One project will leverage an improved mouse model of chronic myeloid leukemia (CML), which suggests
that stochastic, non-genetic transitions are essential in leukemogenesis. The model will be used to
investigate the origins of primary therapeutic resistance and the means by which existing therapies may
be improved. A second project will investigate the origins of melanoma, using mouse models to clarify
the many cellular states that have been distinguished in this cancer and elucidate relationships between
such states and accumulated mutations, arrangements of cells in space, and the microenvironment. The
third project will leverage mouse models of Brca1-driven, triple-negative breast cancer, wherein
observations suggest the existence of a distinct pre-malignant state, seeking to identify the signals and
cell-cell interactions that create and maintain this state, and elucidate the events that allow rare escape
to malignancy. All three projects combine mathematical modeling, genomics, and computational biology.
All three will be served by a shared resource core for analyzing single cell data and providing access to
new and emerging technologies and algorithms. An administrative core and an external scientific
advisory board will assist with management, integration and evaluation of program activities.

Public health relevance
A research program on “Tipping Points in Cancer” will investigate processes at the origin of cancer, focusing on non-genetic steps that interact with cancer-causing mutations to produce rare transitions to malignancy. Collaborative, interdisciplinary projects on leukemia, breast cancer and melanoma will use genetically engineered mouse models, computational biology, and mathematical modeling to address fundamental questions. By focusing on a relatively understudied area in cancer biology, the program seeks to open up new avenues for cancer prevention and treatment.